Susceptibility and Resilience to Adverse Childhood Experiences: A Role for Perineuronal Nets

SUMMARY:
Over 60% of children experience severe stress and are exposed to traumatic events including interpersonal
violence, sexual abuse, accidents and injuries – adverse childhood experiences – but there is a mismatch
between their exposure to these experiences and the prevalence of subsequent psychopathology. This
mismatch, in which most children who experience traumatic events do not show psychopathology, may result
from resilience to the events, a lack of diagnosis, or forgetting about the experiences. Resilience to adverse
events involves responding with minimal distress or an early and effective return to normal levels of function.
Forgetting about traumatic events in the very young – referred to as infantile amnesia – has been associated
with critical periods in development involving the formation and strengthening of perineuronal nets surrounding
neurons in specific areas of the brain related to memory formation for highly stressful events. Disrupting these
perineuronal nets may extend or renew critical periods and help allow the memory of adverse experiences to be
erased. Using a new model of hyperarousal in young rats to model adverse childhood experiences, we will
determine the ontogeny, mechanisms, and treatment of hyperarousal. Our overarching goal is to understand
the hyperarousal that results from stressful events. We will test the hypothesis that resilience to and forgetting
about learning-induced hyperarousal is a function of perineuronal nets that form and strengthen during
development around neurons in the circuits underlying associative learning. To test this hypothesis, we focus
on three specific aims: (1) Characterize the ontogeny of hyperarousal and determine the underlying neural
mechanisms, (2) Determine behavioral strategies to “treat” or mitigate hyperarousal in young rats and delineate
the neural mechanisms involved, and (3) Determine the role of perineuronal nets in hyperarousal and its
treatment. We will conduct a series of experiments in which we characterize hyperarousal in young rats,
determine treatments, and then manipulate perineuronal nets before acquisition or extinction of aversive
associative learning to determine whether we can manipulate critical periods to impair the development or
facilitate the forgetting of hyperarousal as well as the conditioned emotional responding to cues associated with
adverse events. The proposed experiments constitute a concerted effort to fill an important gap in our
understanding of the developmental trajectory of hyperarousal that occurs in children following adverse events
– an area of growing concern as the incidence of interpersonal violence, accidents and injuries to children
continues to escalate both in the United States and abroad. We will focus on mechanistic studies that reveal the
underlying neural processes, the role of perineuronal nets, and elucidate age-specific behavioral and
pharmacological treatment strategies.

Public health relevance
NARRATIVE: Children experience interpersonal violence, sexual abuse, accidents and injuries – adverse childhood experiences – but not all children exposed to these experiences develop psychopathology. These children are resilient, they may go undiagnosed, or they are able to forget about the experiences. We will study adverse childhood experiences in young rats to help develop treatments that allow these memories to be erased.